Vitamin K: Body Pools and Function in Breast Cancer

PROJECT SUMMARY/ABSTRACT
This proposal focuses on the divergent effects of the two major dietary forms of vitamin K on breast cancer. K
vitamins act as cofactors for gamma-glutamyl carboxylase (GGCX), which post-translationally introduces γ-
carboxyglutamate residues into proteins. Although most of the 17 known γ-carboxylated proteins function in
coagulation and bone homeostasis, the presence of GGCX in most tissues (including mammary gland) suggests
more extensive physiological roles for vitamin K. We have demonstrated that triple negative breast cancer
(TNBC) cell lines express GGCX and produce γ-carboxylated proteins in response to vitamin K1 (phylloquinone),
the major dietary form. In TNBC cells, K1 treatment enriches for the stem cell marker aldehyde dehydrogenase
1 (ALDH1) and promotes mammosphere formation. These data suggest that K1 sustains GGXC mediated γ-
carboxylation to drive aggressive breast cancer phenotypes. Through analysis of genomic cancer datasets, we
find that ~25% of breast tumors express GGCX and the vitamin K oxidoreductase (VKOR) genes required for its
activity. Patients with such tumors have poorer survival than those whose tumors do not express these genes at
high levels. Patients with this subtype of tumor would be candidates for therapies that limit K1 availability and/or
inhibit GGCX. Surprisingly, we found that vitamin K2 (menaquinone-4), another naturally occurring form present
in diet, does not stimulate γ-carboxylation or stem cell phenotypes in TNBC cells, but instead strongly suppresses
cell growth, migration and energy metabolism. These provocative data indicate that K1 and K2 exert distinct
effects on breast cancer cells, with K1 promoting and K2 suppressing aggressive phenotypes. We also found
that expression of the vitamin K2 biosynthesis enzyme UbiA Prenyltransferase Domain Containing 1 (UBIAD1)
is undetectable in TNBC, suggesting altered cellular handling of vitamin K. In Aim 1 we will dissect the effects
of K1 and K2 in vitro, evaluate the role of UBIAD1 and conduct feeding studies to measure accumulation of K1
and K2 in TNBC xenografts and host mammary gland in relation to tumor growth. In Aim 2 we will determine
whether deletion of GGCX from TNBC cells impacts γ-carboxylated protein synthesis and aggressive
phenotypes in vitro and in vivo. Aim 3 will identify relevant γ-carboxylated GGCX substrate proteins that mediate
the effects of K1. We anticipate that growth of tumors with high GGCX activity and low UBIAD1 will be stimulated
by high dietary K1 and inhibited by high dietary K2. These findings would identify GGCX as an oncogene and
the vitamin K pathway as a therapeutic target in a subset of patients with advanced breast cancer.

Public health relevance
PROJECT NARRATIVE: This project investigates how vitamin K affects aggressive breast cancers and whether therapies that modulate this pathway could benefit patient survival. Our studies will determine which forms of vitamin K accumulate in breast tumors and how dietary forms of vitamin K influence tumor progression.